Theraputic targeting of pulmonary endothelial cells to inhibit pathological lung remodeling

Summary
Existing anti-fibrotic treatments for pulmonary fibrosis have not significantly improved survival. There is a
critical need for new therapeutic approaches. Pulmonary fibrosis results from dysregulated lung repair and
involves multiple cell types. The role of endothelial cells (EC) in lung fibrosis is poorly understood, even though
lung fibrogenesis is associated with vascular remodeling, increased vessel permeability, hypoxia, partial loss of
capillaries, focal increase in pathological angiogenesis and development of pulmonary hypertension. Our long-
term goal is to develop clinically relevant approaches to correct EC dysfunctions, prevent loss of
microvasculature, and slow down progression of lung fibrosis. Our preliminary data identify FOXF1 as a key
transcription factor in pulmonary endothelial cell functions, down-regulation of which is indispensable for
transition of normal lung EC into fibrosis-associated EC. We also demonstrate that FOXF1 transcriptionally
activates R-Ras, a G protein from Ras family of GTPases, which is shown to be important for lumenization of
newly formed microvessels and maintenance of EC barrier function in mouse models of muscle ischemia and
cancers. Our central hypothesis is that lung EC-specific nanoparticle delivery of FOXF1 or R-Ras or
transplantation of FOXF1+cKIT+ endothelial progenitor cells (EPCs) will improve lung microvascular integrity
and inhibit the progression of pulmonary fibrosis. To test the hypothesis, we propose two specific aims: (1) to
determine whether restoring microvascular integrity via nanoparticle gene therapy will inhibit lung fibrogenesis,
(2) to define whether transplantation of FOXF1+cKIT+ EPCs will restore microvascular integrity and inhibit lung
fibrosis. Altogether, nanoparticle gene therapy or cell transplantation with FOXF1+cKIT+ EPCs have
translational potential in IPF and other pulmonary diseases associated with fibrosis.

Public health relevance
Project Narrative. We propose to develop the new therapeutic approaches to restore microvascular integrity during lung fibrogenesis with the goal to decrease the disease progression. We will use newly developed lung EC-specific nanoparticles and transplantation with donor FOXF1+cKIT+ endothelial progenitor cells to improve lung microvascular integrity and prevent fibrotic lung remodeling. The outcomes from our studies are expected to have an important positive impact on human health because of the high translational potential of the proposed new therapies in IPF.